Short Term Research Training: Students in Health Professional Schools

NIH/NIDDK Project Summary/Abstract
The Yale School of Medicine has a long tradition and record of accomplishments in the training of medical
students for careers in academic medicine and research. The purpose of the renewal is to provide intensive
short-term training in research for selected pre-doctoral medical students in the most outstanding laboratories
and training sites in the Yale School of Medicine. More than half of the students will be engaged in research
projects that are directly relevant to NIDDK areas of research interest, which include diabetes, endocrinology,
metabolic diseases, obesity, nutrition, digestive and liver diseases, and kidney, urologic, and hematologic
disorders. Most will train with faculty holding NIDDK research grants. The program is designed to attract the
most highly qualified Yale medical students into careers as physician-scientists in the biomedical sciences. An
extensive follow-up documents a high level of subsequent research training, research productivity, and faculty
appointments (40.2%) among previously supported students.
Trainees will be chosen upon application of pre-doctoral medical students who have completed in good standing
one year of the curriculum of the Yale University School of Medicine. 30 students per year will be selected
competitively for this short-term training support on the basis of the quality of a formal written proposal of the
planned research and the quality of the mentor and the training environment.
The participating departments and sections will include: biomedical engineering, cellular and molecular
physiology, genetics, immunobiology, internal medicine (sections of cardiovascular diseases, digestive diseases,
endocrinology and metabolism, geriatrics, hematology, nephrology, and rheumatology), laboratory medicine,
neuroscience, pathology, pediatrics, pharmacology, psychiatry, and surgery and related interdisciplinary centers.

Public health relevance
NIH/NIDDK Project Narrative The purpose of this training grant to provide intensive short-term training in research areas of interest to NIDDK for 30 selected pre-doctoral medical students in the most outstanding laboratories and training sites in the Yale University School of Medicine. The specific research experiences will range from fundamental molecular biology, cellular and organ physiology to applied clinical research. The program is designed to attract the most highly qualified Yale medical students into careers as physician-scientists in the biomedical sciences in areas of interest to NIDDK.